Endothelial de novo nucleotide synthesis in atherosclerosis

PROJECT SUMMARY
Atherosclerotic risk factors, including disturbed flow (d-flow), induce endothelial cell (EC) DNA damage and the
subsequent EC death, compromise the integrity of the endothelial barrier, and ultimately lead to the formation of
atherosclerotic lesions. Metabolism such as glycolysis and fatty acid metabolism are reprogrammed to
accommodate ECs to the atherosclerotic environment. Nucleotide metabolism, including purine and pyrimidine
synthesis, has been reported to regulate DNA repair and cell proliferation in cancer cells. However, the role of
endothelial purine and pyrimidine synthesis in atherosclerosis has not been investigated. 5-aminoimidazole-4-
carboxamide ribonucleotide formyltransferase/inosine monophosphate cyclohydrolase (ATIC) and Carbamoyl-
phosphate synthetase 2, aspartate transcarbamylase, and dihydroorotase (CAD) are critical enzymes for de
novo purine synthesis (DNPS) and de novo pyrimidine synthesis, respectively. Recently, I have demonstrated
the pivotal role of ATIC in vascular smooth muscle cells in proliferative arterial disease in rodent models.
However, it remains unclear in the role of ATIC or CAD-mediated de novo nucleotide metabolism in ECs in the
development of atherosclerosis. My preliminary data show that (1) DNA damage response was increased in ECs
exposed to disturbed flow, and this was accompanied by increased ATIC-mediated DNPS and CAD-mediated
de novo pyrimidine synthesis; (2) Knockdown of ATIC with siRNA aggravated EC DNA damage and apoptosis
induced by d-flow; (3) The atherosclerotic lesion size was markedly increased in EC-specific Atic deficient mice
in d-flow-induced mouse atherosclerosis. These data allow me to hypothesize that ATIC-mediated DNPS and
CAD-mediated de novo pyrimidine synthesis in ECs supply nucleotides to repair DNA damage and preserve EC
barrier integrity in vulnerable atheroprone regions and ultimately protect against the development and
progression of atherosclerosis. To test my hypothesis, I have generated endothelial Atic or Cad deficient mice
(AticΔVEC and CadΔVEC) and crossed the mice with ApoE-/- mice to generate ApoE-/-;AticΔVEC and ApoE-/-;CadΔVEC
mice. I will investigate the effect of endothelial Atic or Cad deficiency in the formation of atherosclerotic lesions
using specific genetic tools with an integrated approach of in vivo and in vitro models. The results of this study
will provide insights into how metabolic reprogramming of purine and pyrimidine synthesis in endothelial cells is
involved in the development of atherosclerosis, offering new strategies for its prevention and treatment. This
grant will be critical for me to achieve the following short- and long-term objectives: 1) to acquire additional
scientific training both methodologically and conceptually; 2) to merge the yet distinct metabolism and
atherosclerosis fields with the goals toward opening up new avenues of discovery; 3) to establish an independent
research program; 4) publish high-impact corresponding author articles and develop a highly competitive R01
grant application. I have assembled a multidisciplinary team to guide my career toward independence and assist
with the completion of the proposed research study.

Public health relevance
PROJECT NARRATIVE Endothelial metabolism plays a critical role in regulating endothelial function, and dysregulated endothelial metabolism leads to the development of various vascular diseases, including atherosclerosis. Our proposed study aims to uncover previously unrecognized connections between de novo nucleotide synthesis and endothelial dysfunction within the context of atherosclerosis. The results of our study will provide insights into how metabolic reprogramming of purine and pyrimidine synthesis in endothelial cells is involved in the development of atherosclerosis, offering new strategies for its prevention and treatment.